Rapid Antibiotic Susceptibility Testing via Selective Lysis and Nanogap Trapping

Project Summary
The indiscriminate use of antibiotics has contributed to increased patient toxicity, poor clinical outcomes,
excessive healthcare costs, and the widespread and increasing emergence of antibiotic resistant strains. Current
clinical practice is driven by the limits of existing technologies for guiding rational treatment selection. Antibiotic
susceptibility tests based on cell culture are too slow to support treatment selection during the critical early stages
of infection, and although genotypic assays can be performed within several hours, genetic markers of resistance
are not known for all mechanisms, nor is resistance assured when a particular sequence is present. Overcoming
these limitations demands an alternate approach based on rapid phenotypic and culture-free susceptibility
profiling, thereby allowing clinicians to move beyond the empiric antibiotic selection process by quickly identifying
causative bacteria and evaluating their response to targeted antibiotics. Here we propose a unique platform to
address this need based on a simple, inexpensive, and rapid microfluidic-enabled technology. The platform will
isolate small numbers of bacteria directly from whole blood, identify bacterial pathogens, and evaluate their
antibiotic response within 75 min from initial blood draw. These capabilities will be enabled by two complementary
technologies. First, a novel porous silica monolith will be used to selectively lyse blood cells while passing
bacteria in a high-throughput continuous-flow process, generating a solution of intact and viable bacteria directly
from whole blood. Second, small numbers of bacteria present in the initial sample will be captured, purified, and
concentrated within a passive nanogap trap capable of isolating bacteria at precisely defined locations. Each
trap will consist of a narrow chamber terminating at a sharp tip, with a sub-micrometer gap surrounding the
chamber periphery to allow blood lysate particles to be removed while concentrating bacteria at the chamber tip
during sample perfusion. The nanogap chambers will constrain bacteria to defined regions with a total volume
below 1 pL, enabling sensitive and rapid analysis of the immobilized bacteria by fiber optic Raman spectroscopy
down to the level of single organisms, allowing for bacteria identification using a machine learning based
classifier, followed by evaluation of pathogen response to antibiotic exposure to determine susceptibility to the
selected drug. By taking advantage of the high concentration factor provided by the nanogap trap, the system
will provide susceptibility testing within 75 min using blood samples with bacteria concentrations below
10 CFU/mL. System performance will be evaluated using wild type and antibiotic-resistant organisms, with
bacteria response characterized for multiple classes of antibiotics using a low-cost fiber optic Raman
spectrometer for detection, and validation of the resulting technology will be performed using whole blood
specimens from patients treated for bacterial infections at the University of Maryland Medical Center.

Public health relevance
Project Narrative New tools for the rapid evaluation of antibiotic susceptibility directly from patient samples are needed to address the increasing prevalence of antibiotic-resistant bacteria. Rapid and low cost assays capable of guiding the optimal selection of antibiotic treatment will have a significant impact on improving patient health and reducing the unnecessary use of broad spectrum antibiotics. This effort will yield a simple and inexpensive microfluidic platform that employs a novel approach to isolating and interrogating bacteria directly from whole blood, enabling antibiotic susceptibility screening within 75 min to allow clinicians to select an appropriate treatment at the earliest stages of infection.